Psychological deficits after low level blast exposure: role of neurovascular disruption

Many Veterans experience occupational exposure to low-level blast (LLB) during normal training operations,
including but not limited to breaching activity. These Veterans are at increased risk for persisting
neuropsychological impairment due to repeated LLB exposure over several deployments with limited time for
recovery between exposures. The extent of the long-term consequences after cumulative LLB exposure is
unknown, though reports show that deficits can be present late in life. Furthermore, the resultant post-traumatic
stress disorder (PTSD)-related behavioral deficits are more pronounced in soldiers and Veterans with a history
of chronic blast exposure. There is no clear understanding of which pathological mechanisms drive this chronic
PTSD phenotype after LLB exposure. A few animal models have been established to address this incomplete
understanding of the pathobiological mechanisms underlying LLB exposure. These models replicate the
chronic depressive, anxiogenic, and PTSD-related traits observed in Veterans, though there are many
knowledge gaps in what contributes to these chronic deficits. In general, blast exposure causes acute blood-
brain barrier (BBB) and neurovascular unit abnormalities that can persist over time. The overall objective of this
application is to determine the timing of acute neurovascular dysfunction after LLB and how repeating LLB
contributes to chronic neurovascular impairment and neuropsychological deficits. Our central hypothesis is that
LLB repeated at a time interval of maximal BBB impairment, after the first LLB, will result in persistent PTSD-
like behavioral traits. Additionally, these deficits will be associated with changes in the profile of serum-derived
exosomal miRNAs and platelet bioenergetics. These hypotheses were formulated based on current literature
and our own published and preliminary data demonstrating anxiety and amygdalar BBB disruption after blast
exposure. By utilizing a multimodal blast simulator at the University of Kentucky, these studies will be able to
examine the longitudinal behavioral profile, coupled with pathologically relevant biomarkers. These hypotheses
will be tested in three specific aims: 1) examine acute neurovascular deficits after a single LLB exposure and
determine their relationship to longitudinal behavioral traits, 2) determine how repeating LLB at various time
intervals, based on the acute neurovascular profile, contributes to exacerbated or prolonged PTSD-like
behavioral traits and chronic neurovascular impairment, 3) identify if modulating either acute or chronic
neurovascular health using sildenafil will mitigate long-term PTSD-like behavioral traits. This research will
drastically improve our understanding of the effects of LLB as well as potentially identify novel, clinically-
relevant biomarkers. The proposed research is significant because it will establish a platform to understand the
chronic effects of occupational blast exposure, which affects many Veterans. In addition, this line of
investigation can lead to better therapeutic targeting of neurovascular dysfunction to improve neurological
outcome in aging Veterans. In addition to the research products gained by this proposal, the applicant will
greatly benefit from a mentoring team that has a variety of preclinical, translational, and clinical perspectives,
which will contribute to a well-rounded career development plan. The training program will add additional
techniques to Dr. Hubbard’s’ repertoire, contributing not only to this proposal but to his VA research program
moving forward. With prior knowledge in blast injury modeling, additional behavioral and biomarker assays will
greatly advance his research expertise. In the latter years of this proposal, Dr. Hubbard will continue to expand
grant writing, student mentoring, collaborative research and presentation skills required of independent
researchers. Overall, the proposed studies and diverse mentoring program will culminate in producing a highly
successful independent VA researcher.

Public health relevance
Many Veterans experience low-level blast (LLB) exposure during tour of duty and training operations. The extent of chronic post-traumatic stress disorder (PTSD) traits after cumulative LLB exposure is unknown. Additionally, there is no clear understanding of which pathological mechanisms drive impairment after LLB exposure. The overall objective of this application is to determine the timing of acute neurovascular dysfunction after LLB and how repeating LLB contributes to chronic neurovascular impairment and neuropsychological deficits. We will examine the behavioral profile and neurovascular outcomes after LLB, coupled with pathologically relevant biomarkers. This research will improve our understanding of the effects of LLB and identify biomarkers for neurological injury. The proposed mentored research plan will increase understanding of the chronic effects of occupational blast exposure to identify therapies which will improve Veteran health while providing a foundation for the applicant’s independent VA research program.